Evolutionary conservation of amacrine cell types in the vertebrate retina

PROJECT SUMMARY
Neural circuits derive most of their computational power from inhibitory interneurons, which balance excitation,
enhance contrast, and provide temporal-spatial precision. In the retina, amacrine cells (ACs) are the largest class
of inhibitory interneurons, providing critical inhibition and modulation to bipolar cells and ganglion cells through
their release of GABA or glycine. ACs are incredibly heterogeneous, comprising as many as 60 types that
perform distinct computations and expand the repertoire of visual features relayed to the brain. However, over
80% of these AC types have not been functionally characterized. This is largely due to a lack of molecular
markers to genetically target these types for morphological and physiological experiments in animal models.
Furthermore, since AC types are also morphologically complex, they often lack clear orthologs in other species,
making it difficult to identify their conserved biological function. The overarching objective of this proposal is to
map AC types across species and identify conserved molecular markers with which to target these types for
functional experiments. Recent work in our lab showed that bipolar and ganglion cell types in the retina are highly
conserved across mammals. Although this study omitted AC types due to their complexity, our preliminary
computational analysis suggests that AC types can be molecularly aligned between primates and rodents.
Consistent with these findings, more recent experimental and genomic studies revealed that the direction-
selective and scotopic circuits – key AC-driven circuits – are present in fish. Based on these observations, we
hypothesize that AC diversity is evolutionarily ancient and that AC types are broadly conserved across
vertebrates. To test this hypothesis, we will use single-cell RNA-sequencing atlases of ACs recently generated
in our lab to guide a series of computational and experimental studies. Aim 1 will investigate the molecular
conservation of ACs across 20 vertebrates by aligning single-cell atlases and building upon existing comparative
transcriptomic methods. Aim 2 will identify novel, conserved molecular markers of AC types and label them in
primates, rodents, and chicken using histology. Experiments in Aim 3 will investigate the circuitry and function
of a highly conserved, novel AC type marked by PDGFRA. Together, these data will describe the molecular and
structural conservation level of ACs and reveal new aspects about their cellular properties. Importantly, we will
identify and test novel molecular markers of specific AC types that will be useful for targeting them in future
studies. This proposed work has broad implications for uncovering contributions of inhibitory interneurons to
retinal processing.

Public health relevance
PROJECT NARRATIVE Amacrine cells perform essential computations (e.g. motion detection, contrast sensitivity, light adaptation) and critically shape the output of the retina in ways that remain poorly understood. This work will map amacrine cell types across species and establish methods to target these types in multiple animal models, providing direct avenues for characterizing their function in health and investigating their dysfunction in disease. Advancing knowledge about amacrine cells can inform strategies for retinal repair, prosthetic development, and other therapeutic interventions aimed at preserving or restoring vision.